Gardner Lab MIRA Proposal: Microtubules and Mitosis

The Gardner Laboratory uses a combination experimental and computational approach to
dissect molecular mechanisms for how microtubule lengths are regulated inside of cells, and for
how forces within the mitotic spindle act to ensure proper chromosome segregation during
mitosis. We use biophysical computational modeling to better integrate and understand our
experimental observations, make new experimental predictions, and to test whether our
proposed cellular mechanisms are physically reasonable. Overall, we are a cellular biophysics
laboratory that combines cell biology tools with biophysical methods to shed new light on the
regulation of microtubule dynamics, and to dissect forces and their consequences in mitosis.
Achieving the goals described in this application will provide mechanistic insights into how
molecular-scale changes in microtubule structure could regulate cellular-scale changes in
microtubule-associated protein localization and binding, as well as how controlled mitotic forces
could act to protect genome integrity during mitosis. In particular, this application will advance
our understanding of: 1) how microtubule structure can alter protein binding, and vice versa, 2)
how the cell reads out and responds to nuanced tension signaling during mitosis, and 3) how
controlled anaphase forces could act to protect genome integrity during anaphase.

Public health relevance
Mitosis is the process by which duplicated sister chromosomes are evenly distributed to identical daughter cells, and in cancer cells, improper chromosome segregation during mitosis (e.g., such that chromosomes are unevenly distributed between daughter cells) is widely observed, and has been linked to poor prognosis, including decreased overall survival time and fewer treatment free years. In this study, we will make use of physical principles and advanced microscopy to evaluate the role of controlled forces in ensuring proper chromosome segregation during mitosis, and to dissect the role of microtubule structure in the targeting of microtubule- associated proteins. The results generated from our studies will be applicable both towards better understanding the fundamental biophysics of cell division, and also towards providing mechanistic information to shed light on current cancer therapies.